Transcriptional regulatory mechanisms shaping HIV proviral fate

PROJECT SUMMARY
Although HIV-1 infection can be controlled through long-term treatment with anti-retroviral therapy (ART), a
true cure has been elusive. Reservoir cells persist over time and support latent HIV-1 reactivation upon therapy
cessation, yet little is known about the underlying mechanisms. Our lab has recently identified previously
unknown facets in the “core” HIV-1 transcriptional program that we will explore in this proposal to help fill this
knowledge gap, and may offer key insights into HIV-1 biology as well as cure strategies. The major goal of this
grant application is to understand transcriptional regulatory mechanisms shaping HIV-1 latency maintenance
and reactivation. We will accomplish this goal by leveraging genetic, genomic and microscopy approaches to
explore HIV-1 transcription at high-resolution in several immortalized and primary models of latency as well as
in aviremic participants samples.
We will focus on the cycle of RNA polymerase II (Pol II) transcription, which is essential for the process of
latency reactivation in reservoir cells. Specifically, we will explore the hypothesis that HIV-1 transcription is initially
activated by de novo Pol II recruitment through the action of viral enhancers and eukaryotic transcription factors
-TFs- (host phase) and later sustained through Tat-dependent Pol II re-initiation (viral phase). We propose to
build on our recent findings to gain a deeper understanding of how the viral enhancers promote HIV-1
transcription for latency reactivation in the host and viral phases of the HIV-1 transcriptional program. These
goals are reflected in two Specific Aims: to define the viral enhancers that drive HIV-1 transcription and latency
reactivation (Aim 1), and to determine how eukaryotic TFs and Tat function with the viral enhancers to facilitate
HIV-1 transcription and latency reactivation. If successful, this project will yield a better understanding of the
molecular mechanisms by which eukaryotic TFs and Tat converge to promote efficient HIV-1 transcription and
latency reactivation, collectively having a sustained impact in the field. In keeping with NIAID’s mission of ending
the HIV-1 epidemic, our long-term objective is to leverage the basic discoveries to devise novel and alternative
cure strategies. As such, the fundamental knowledge gained by this research could be used in the future studies
beyond the scope of this focused grant application, to exploit an enhancer-based strategy to permanently silence
HIV-1 to achieve the long-awaited HIV-1 remission.

Public health relevance
PROJECT NARRATIVE The major goal of this application is to define how the viral enhancers facilitate HIV-1 transcription initiation by eukaryotic transcription factors and/or sustain Tat mediated re-initiation. This project will yield a better understanding of the molecular mechanisms by which eukaryotic transcription factors and Tat converge to promote efficient HIV-1 transcription and latency reactivation. Our basic research findings should also suggest novel strategies for designing rational, alternative strategies towards a functional cure.